Decoding the language of inflammation between central nervous system resident immune cells

SUMMARY
Interactions between central nervous system (CNS)-resident cells are highly heterogeneous; astrocytes and
microglia nourish and protect neurons, while inflammatory subsets drive demyelination and neurodegeneration
in neurologic diseases. However, the molecular mechanisms that control CNS-resident immune cell
interactions remain mostly unknown because methods for defining the specific cell types, pathways and
molecules involved are limited. In this project we apply two novel approaches that we developed to study
astrocyte-microglia interactions during inflammation: 1) an in vivo barcoded rabies tracing strategy that
analyzes cell connections and transcriptomes with single cell resolution, and 2) a droplet-based platform for
genome-wide, unbiased CRISPR/Cas9 screening of interacting cell pairs. These methods provide a unique
opportunity to study pathways used by CNS-resident immune cells to communicate with each other and control
inflammation and neurodegeneration. We propose to:
SPECIFIC AIM 1: Define the transcriptomes of single cells in pro-and anti-inflammatory networks. We
will simultaneously sequence connections and single cell transcriptomes of CNS cells in the experimental
autoimmune encephalomyelitis (EAE) mouse model of multiple sclerosis (MS). These studies will identify pro-
and anti-inflammatory cellular networks and the molecular mechanisms that regulate disease-relevant cell-cell
interactions within these networks.
SPECIFIC AIM 2: Identify novel astrocyte-microglia interactions using a droplet-based platform for
CRISPR/Cas9 forward genetic screens. We will perform unbiased genome-wide screens for genes that
participate in microglia-astrocyte crosstalk. We will co-incubate and microfluidically sort millions of picoliter
water-in-oil droplets containing single microglia harboring a CRISPR/Cas9 library mutation and single
astrocytes carrying a fluorescent reporter. Independent droplets do not mix, providing a powerful platform for
the identification of immune interactions mediated by cell surface and soluble molecules.

Public health relevance
NARRATIVE Central nervous system (CNS)-resident astrocytes and microglia interact to regulate pro-inflammatory programs that drive neurodegenerative diseases, but the pathways and molecules involved are largely unknown. Understanding the language of inflammation is a central question in the field of Neuroimmunology and may guide new therapeutic approaches for multiple sclerosis and other neurologic diseases. This proposal applies two novel high-throughput methods to study microglia-astrocyte interactions during CNS inflammation.